Developing a novel epigenetic regulator as a treatment for cocaine use disorder

Developing a novel epigenetic regulator as a treatment for cocaine use disorder
Project Summary/Abstract
Cocaine use disorder (CUD) is a major public health problem that is associated with substantial morbidity
and mortality. Treatment for CUD primarily consists of behavioral interventions including contingency
management, cognitive behavioral therapy, or therapeutic communities. However, these approaches result in a
substantial relapse rate in those seeking treatment, and despite efforts to develop pharmacological agents, no
medications have been proven safe and effective for the treatment of CUD. One reason that people with CUD
have difficult quitting and remaining abstinent is the intense drug-related contextual memory that links drug use
to euphoria-like feelings. We have recently identified a novel mechanism of that promotes neuronal plasticity and
memory consolidation/reconsolidation via ACSS2, a metabolic enzyme that regulates histone acetylation and
Immediate Early gene expression involved in memory formation and retrieval. We hypothesize that small
molecule inhibitors of ACSS2 will selectively disrupt drug and cue-related memory reconsolidation, leading to
diminished drug craving, thereby enabling preventing relapse in people with CUD. Using a commercially
available ACSS2i (ADG-205), we have demonstrated that acute inhibition of ACSS2 can decrease relapse
behavior in several pre-clinical models of substance abuse, including nicotine, alcohol, opioid and cocaine. While
ADG-205 has proven efficacious, we cannot patent the molecule and we have observed some less than ideal
pharmacological properties. Through medicinal chemistry efforts, we generated 55 new compounds. One
compound in particular, EPV, exhibits a novel scaffold, with improved efficacy and brain bioavailability.
The aim of this application is to establish EPV as a viable new generation of ACSS2 inhibitor through 2
ams. Aim 1 will assess pharmacological parameters such as selectivity, functional efficacy on histone acetylation
and gene regulation, ADME properties and basic pharmacokinetics. Aim 2 will focus on testing our novel scaffold
in a pre-clinical model of cocaine use called intravenous self-administration. Additionally, we will confirm that
EPV treatment does not affect learning and non-targeted memories.
These studies will yield a novel lead candidate molecule with improved pharmacological properties, which
will lead to a new program of medicinal chemistry to develop new drug candidates. Overall, our program
proposes an entirely new mechanism of action for treating cocaine addiction. Significant strengths of the
application include the novelty of the proposed target, required in vitro and in vivo assays already in place, and
a novel chemical scaffold to initiate drug development.

Public health relevance
Developing a novel epigenetic regulator as a treatment for cocaine use disorder NARRATIVE Cocaine is an addictive stimulant drug that is at the root of 1.3 million people in the US being afflicted with cocaine use disorder (CUD) and nearly 19,447 people dying from cocaine-related overdose in a recent year, which is even more alarming knowing there is no approved pharmacotherapies. The current standard of care for CUD consists of behavioral interventions including contingency management (i.e., motivational incentives), cognitive behavioral therapy, or therapeutic communities (i.e., drug-free residencies), which remain prone to noncompliance by the patients and have relapse rates of 20-25%. The problem is the intense cocaine-taking euphoria memories and the overwhelming urge that it causes; however, the pharmacotherapeutic we plan to develop will solve this problem by attenuating the problematic craving urge.